Preoperative exercise therapy modulates neutrophil extracellular trap formation

PROJECT DESCRIPTION: The goal of this Administrative Supplement application is to support an
undergraduate student to obtain the authentic research experience during this summer by determining the
mechanism by which preoperative exercise therapy modulates the capability of neutrophils forming neutrophil
extracellular traps (NETs), which is highly relevant to the parent grant (R01GM137203) entitled "Preoperative
exercise therapy for surgery triggered inflammation". Liver ischemia and reperfusion (I/R) is an unavoidable
consequence of major liver resection and liver transplantation that leads to significant morbidity, mortality, and
costs after liver surgery. However, previous strategies to protect the liver from I/R injury have focused on one
specific known injury mechanisms, leaving intact other detrimental processes. Pre/post-operative exercise
facilitates recovery after major abdominal surgery. It is known that exercise confers beneficial effects on the
surgical outcome by regulating multiple mechanisms, including alteration of quantity and function of innate
immune cells to provide an anti-inflammatory environment. We have discovered that preoperative exercise
therapy (PET) significantly reduced serum aminotransferase levels (liver damage) and expression of cytokines
and chemokines (inflammatory responses) during liver I/R via metabolic reprogramming Kupffer cells from pro-
inflammatory to ani-inflammatory phenotype. However, even though cellular energy metabolism and
mitochondrial biogenesis play a critical role in the immune response, the effects of PET-induced changes in
neutrophils forming neutrophil extracellular traps (NETs) have never been studied. The undergraduate summer
research program at Feinstein Institutes for Medical Research is a well-established research program that
support undergraduate students who are considering pursuing biomedical research careers in cutting-edge
scientific environments during the summer. Our proposed studies which will be conducted by undergraduate
student will significantly expand the scope of the parent R01 award by interrogating two new questions related
to those already being investigated in the parent R01 award: 1) What is the role of PET in the transcriptomic
changes of infiltrating neutrophils after liver I/R? 2) Do PET-trained KCs suppress NET formation during liver
I/R? In summary, the mentored studies that performed by undergraduate student in the Summer Research
Program will significantly expand the current understanding of the underlying mechanistic mechanisms by
which PET prevent surgical stress-induced organ injury via modulating NET formation and evaluate novel
potential therapeutic targets, and assess promising novel treatments for patients undergoing surgery.

Public health relevance
Project Narrative Preoperative exercise therapy (PET) is a highly applicable non-pharmacological-based therapy and has successfully reduced postoperative complications and conferred better recovery from major liver surgery. This project will determine the mechanisms by which PET prevents liver ischemia/reperfusion injury which is an unavoidable consequence of major liver surgery by altering the trained immunity in hepatic resident macrophages (Kupffer cells), and the NET-induced local and systemic inflammatory response. The finding from this proposal will provide the knowledge foundation for not only optimizing the development of PET against surgery-induced organ injury but also devising exercise-mimicking pharmacological strategies for patients who are exercise intolerant.